Assessment of a novel tau propagation pathway from layer II medial entorhinal cortical neurons to CA1 pyramidal neurons as an early Braak stage mouse model

Abnormally phosphorylated microtubule-associated protein tau (p-tau) is one of the diagnostic hallmarks of AD
pathologies, which strongly correlates with synaptic loss and cognitive decline in AD. Tau pathology first
appears in the transentorhinal cortex and entorhinal cortex layer II (EC II), then spreads to the Cornu Ammonis
1 (CA1) field of the hippocampal region at the prodromal stage of AD (Braak stage I-II). However, no animal
model has ever succeeded in showing tau propagation from EC II specific to CA1 as typically seen in the early
Braak staging. A recent study has discovered that Wolfram syndrome-1 (Wfs1) positive cells in EC II project to
CA1 via the stratum lacunosum moleculare along the temporammonic (TA) pathway. We hypothesize that
misfolded tau propagates from Wfs1+ cells in EC II to CA1 via the TA pathway, and that the TA pathway is a
novel therapeutic target to suppress tau propagation in the prodromal AD stage. Our exciting preliminary data
showed that the stereotaxic injection of adeno-associated virus expressing Cre-inducible P301L tau into EC II
of Wfs1-Cre mice induced: 1) robust human tau transfer from EC II to CA1 pyramidal neurons, 2) direct tau
transfer between axonal terminals of Wfs1+ EC II neurons and dendrites of CA1 pyramidal neurons, 3)
suppression of excitability of CA1 pyramidal neurons, and 4) impaired associative working memory. Thus, this
new mouse model may recapitulate tau pathology progression from Braak I to II, and develop
neurophysiological dysfunction and hippocampal learning impairment. The object of this current application
is to fully characterize the pathology of this EC II-CA1 tau propagation mouse model and delineate the
connectivity and mode of tau transmission from EC II to CA1. Our overarching goal is to invent therapeutics
for prodromal AD using this mouse model. In Aim 1, we will i) characterize the post-translational modification of
tau and cell types in EC II-CA1 mice using multiple p-tau antibodies and neuronal specific markers. ii) Validate
the translatability of the findings in human AD brain tissues using early Braak stage and age/sex matched
control specimens.iii) Investigate the gene expression profiles in EC, CA1, and prefrontal cortical regions of
male and female mice to understand the molecular basis of sexual dimorphism in the behavioral outcome. In
Aim 2, we will i) employ immuno-electron microscopy and super-resolution confocal microscopic imaging to
capture tau transfer between EC II axonal terminals and radial dendrites of CA1 pyramidal neurons;ii) explore
monosynaptic tracing between CA1 pyramidal cells and EC II neurons using Cre-dependent complementation
of a modified rabies virus and WGA-GFP reporter system, and iii) determine the effect of activating/inhibiting
neuronal firing on tau propagation, the role of neuronal extracellular vesicle release, and LDL Receptor Related
Protein 1 as the predicted receptor for free tau secreted from the synaptic terminals. The proposed research
project will develop a new understanding of tau propagation mechanism seen in the early Braak stages and
provide a new insight for the sexual dimorphism in cognitive phenotype.

Public health relevance
The goal of this current application is to fully characterize a new animal model mimicking the tau pathology development and cognitive dysfunction as seen in the early stage of Alzheimer’s disease. We will map the synaptic pathways mediating disease progression by activating or inhibiting specific synapses, and then evaluate the effect of amyloid deposition for acceleration of tau accumulation. Characterization of the new animal model will be beneficial for the development of effective therapeutic interventions.